Embryonic Cell Recognition: Specificity Determinants

This project continues long term studies into mechanisms of morphgenesis. Here the focus is on an
investigation into an Epithelial to mesenchymal transition (EMT). The goal is to understand how this complex
morphogenetic movement works at a molecular level. The EMT is an essential morphogenetic movement used
by almost all animals. Its failure contributes to a number of birth defects, and it is also co-opted, at least in
part, by metastatic processes of carcinomas leading to the spread of tumors.
The model system used here is the sea urchin skeletogenic cells which undergo an EMT synchronously at 9 hr
after fertilization. Knowledge of the cells, the known timing of the EMT, and many experimental tools for this
system provide an excellent model for discovery of how the process works. A number of assays and
approaches enable the EMT process to be studied in detail at a molecular level as it occurs in this system. Prior
research identified essential transcription factors that regulate the component processes of the EMT. Distinct
transcription factors regulate activation of motility, basement membrane remodeling, cell polarity change, and
de-adhesion. To build on this foundation, the proposal is for studies to identify molecular effectors
downstream of those transcription factors. The effectors already obtained, and those sought, control the on-
time delivery of signals to activate the motility, conduct the basement membrane remodeling, regulate the
de-adhesion, coordinate the several component processes, and convert the epithelial membrane into a
functioning mesenchymal membrane. The project is enabled by a number of advances in the past funding
cycle. RNA-seq and scRNA-seq databases recording temporal transects through the EMT interval were
obtained. A pipeline was established to identify candidate molecules, authenticate their participation, and
identify the role they play in the EMT process. Additional candidates will be obtained using these systems
level databases. New molecular tools were advanced so that multiple approaches are available for testing and
authenticating candidate participation and function. In addition, two other tissues that undergo later
synchronous EMTs have been added to the project. Pigment cells and blastocoelar cells each undergo EMT 3
hrs and 7 hrs after the skeletogenic cells. These additions enable us to determine which effectors are used for
one, two, or all three of the EMTs. Although preliminary evidence indicates that even though the three cell
types are derived from mesodermal precursors in the embryo, their EMTs are conducted by largely
independent molecular components. Nevertheless, there is some overlap so it is important to learn which
components are unique to a particular EMT and which may be more universal. Before translational advances
can be applied it is necessary to understand the EMT sequence in detail and to know which molecular
pathways are universal. This project therefore is of great value in gaining a detailed understanding of how the
EMT works.

Public health relevance
An epithelial-mesenchymal transition (EMT) occurs in almost all animals, moving cells that originate in an epithelium to produce the connective tissue of the embryo. In embryos this process must be completed, and in carcinomas the EMT process is co-opted and must be stopped. Thus, in order to prevent birth defects, and to stop metastatic events it is crucial to understand how the EMT works, which is the goal of this project.